FOLATE AND OTHER COFACTORS IN THE METABOLISM OF PHENYTOIN IN PREGNANT WOMEN

The goal of this study is to evaluate the effect of phenytoin and carbamazepine on folate, zinc, vitamin B12 and urinary biotin during pregnancy and at various intervals postpartum.